The topology of protein-protein interactions in situ in eukaryotic cells

Following my recent arrival at the National Cancer Institute, Center for Cancer Research, I am currently in the process of establishing my lab within the Center for Structural Biology. This includes acquiring key reagents and the necessary equipment and technology for carrying out my research and completing the required training. I am also taking steps to recruit several postdoctoral fellows. I await the arrival and installation of key pieces of equipment including the mass spectrometer. I anticipate initiating research studies before the end of the fiscal year.